Assessing Mechanisms of Action in Family Intervention: The Roles of Empathic Communication and Perceived Understanding

PROJECT SUMMARY
Marital conflict is linked with a wide range of adjustment problems in both children and adults, and interparental
conflict may trigger parent-child conflict, causing cascading and reciprocal effects for the entire family.
Consequently, the way in which family conflicts are behaviorally expressed and managed is critical for family
well-being. The degree to which conflicts are communicated and resolved in a constructive versus destructive
manner greatly influences long-term relational satisfaction and child development. Research has yet to
disaggregate the range of processes accounting for beneficial effects of RCT trials designed to increase
constructive behavior on family outcomes, however, so the psychological mechanisms through which positive
changes operate are unclear. Thus, a critical need exists to identify these mechanisms of change through
multi-method, process-oriented analyses. My objective is to evaluate responses associated with an
intervention, the Family Communication Project (FCP), to test the central hypothesis that empathic
communication and perceived understanding are key mechanisms that help explain how the intervention
improved short-term conflict resolution and long-term emotional security and relational satisfaction within
families. The FCP was a multi-component four-week psycho-educational RCT intervention that focused on
family conflict, communication, and adolescent adjustment. Participants consisted of a community sample of
adolescents and their two primary caregivers (N = 225 families). Each family was randomly assigned to one of
two treatment groups or one of two control groups. Assessments were conducted out to 3-years post-
intervention, including observational coding of laboratory-based conflict discussions, daily dairies about family
conflict in the home, self-report questionnaires, and qualitative interviews. My project is guided by the following
three aims: (1) Model the micro-level effects of interspousal support during conflict interaction; (2) Evaluate
support and perceived understanding as longitudinal mediators of intervention effects on marital satisfaction,
adolescent emotional security, and adolescent adjustment; and (3) Conduct thematic analysis of interviews to
contextualize and corroborate the quantitative findings. These analyses may advance empirical and theoretical
bases for understanding the processes associated with constructive family conflict behavior, as well as how
changes in behavior are causally linked to relational family outcomes. These analyses may also help inform
the design of more effective or tailored family interventions. Finally, this proposal reflects an innovative use of
mixed methods to corroborate causal inferences and examine longitudinal change. Goals of the fellowship
training plan, which will take place at the University of Notre Dame, include: (1) Develop conceptual and
methodological expertise in family conflict communication processes and prevention/intervention research; (2)
Expand my expertise in data science, advanced quantitative analysis, and qualitative research methods; and
(3) Develop practice-based skills in family and organizational conflict resolution.

Public health relevance
PROJECT NARRATIVE Marital conflict is linked to a wide range of severe adjustment problems in both children and adults, so a critical need exists to identify mechanisms of constructive prevention and intervention through multi-method, process- oriented analyses. The goal of this research is to test the hypothesis that empathic communication and perceived understanding are key mechanisms that help explain how an RCT intervention improved short-term conflict resolution and long-term emotional security and relational satisfaction within families. This project has the potential to advance understanding of how constructive family conflict behavior is causally linked to relational family outcomes, and it may therefore inform the design of more effective family interventions.